Administrative supplement to promote diversity in health-related research: Melisa Gonzalez

Project Summary/Abstract
The nematode Caenorhabditis elegans relies on small-molecule signals to control its development, metabolism,
physiology, and behavior, and these signals play conserved roles in many parasitic nematode species. This
MIRA application outlines our ongoing efforts to understand the structures, biosynthesis, and mechanisms of
several important classes of small-molecule signals, including (1) the ascarosides – a broad family of
pheromones secreted by C. elegans that the worm uses to induce the stress-resistant dauer larval stage and to
coordinate various behaviors, (2) the N-acyl glutamine nacq#1 – a pheromone that males preferentially secrete
to counter the effects of dauer-inducing ascarosides on hermaphrodites and promote reproductive development,
and (3) the nemamides – a family of hybrid polyketide-nonribosomal peptides that serve as hormones in the
worm and promote starvation survival through a poorly understood mechanism. We target the biosynthetic
pathways to these signaling molecules in vivo by generating precise mutations in the worm genome using
CRISPR-Cas9 and analyzing the effects of these mutations on the primary and secondary metabolome of the
worm using comparative metabolomics. This approach enables us to map the biosynthetic pathways to these
natural products, to identify additional signaling molecules produced by these pathways, and to determine how
these pathways intersect with other metabolic pathways in the worm. We rigorously confirm the role of specific
enzymes in the pathways by reconstituting the pathways using in vitro enzymatic assays, organic synthesis of
biosynthetic intermediates, and structural studies. With the support of this award, we will investigate the
biosynthesis and mechanism of the nemamides, as well as the biological roles of the two essential and enigmatic
neurons where the nemamides are produced, the canal-associated neurons (CANs). We will use nemamide
biosynthesis, which requires genes that are distributed throughout the worm genome, to understand how the
biosynthesis of complex secondary metabolites is controlled in the context of an animal system. Furthermore,
we will investigate how this biosynthetic pathway intersects with the biosynthetic pathways of other secondary
metabolites, including the ascarosides and nacq#1. A central focus will be how the worm regulates the
production and trafficking of these different small-molecule signals in response to different factors and
environmental conditions in order to coordinate its development, metabolism, and physiology. This work will
provide insights into how C. elegans and other nematode species use small-molecule signals to control important
conserved downstream signaling pathways, such as the insulin pathway. Furthermore, given the conservation
of these small-molecule signals in parasitic nematode species, this work will provide new chemical tools and
strategies to interfere with the life cycles of those nematodes.

Public health relevance
Project Narrative Many nematode (roundworm) species are parasites of humans, livestock, and crops, infecting one-third of humans world-wide and causing billions of dollars in agricultural losses. An understanding of the chemical signals used by nematodes to control their development will provide new strategies and chemical treatments to interfere with the life cycles of parasitic species and reduce their survival.